The Virginia Advancing Cancer Control Engaged Research through Transformative Solutions Center

ADMINISTRATIVE CORE: PROJECT SUMMARY
The Administrative Core for the Virginia Advancing Cancer Control Equity Research Through Transformative
Solutions (VA-ACCERT) Center will provide support for the Center’s overarching goal to improve dissemination
and implementation of cancer prevention services to individuals and families living within Virginia’s Housing and
Urban Development (HUD)-administered public housing communities. The Administrative Core provides an
essential framework for coordinating and communicating across the interdependent components of this proposal
as well as supporting the more routine administrative tasks associated with a large, multi-component award. The
Administrative Core will be led by a Multiple Principal Investigator (MPI) triad and an Executive Steering
Committee, and both will be guided by two Community Advisory entities, an Internal Advisory Board, and an
External Scientific Advisory Board. The Administrative Core is charged with the following aims: 1) Provide
oversight and logistical support, including the management of internal and external communications, across all
Center and national consortium activities; 2) Monitor the fiscal oversight for the VA-ACCERT Center; 3) Provide
support for capacity building activities, notably in inclusion and training of early-career trainees and investigators
in the best practices for conducting community-engaged and cancer equity-focused research;
and 4) Implement
comprehensive formative and summative evaluation strategies in coordination with the Center’s leadership and
advisory committees.